Graduate Training Program in Bioinformatics

? DESCRIPTION (provided by applicant): Biology is increasingly becoming an information-driven science. To harness the opportunities of the post-genomic era in furthering health sciences research and improving health care, there is an enormous demand for biologists who are trained in mathematics and computer science and can think quantitatively. However, current disciplinary graduate training programs are not designed to accommodate these rapid changes in the biological research perspective. This need serves as the motivation for the development of specialized graduate training programs that will train students at the interface between biology, engineering and computer science. To address this need, UCSD established an interdisciplinary Graduate Program in Bioinformatics in 2001 under the directorship of Dr. Shankar Subramaniam. In 2008, it was renamed Graduate Program in Bioinformatics and Systems Biology and reorganized. The current directors are Dr. Vineet Bafna and Dr. Bing Ren, and the continued guidance from Dr. Subramaniam and an active steering committee containing representative faculty from all five participating UCSD schools and academic divisions. The primary objectives of this renewal application of the Training Grant by the three co-PIs are to continue and expand this premier Graduate Program, support the highest quality students in their truly interdisciplinary training which blends biomedicine, computer science and engineering. The Program will continue to evolve the curriculum (including online offerings) and develop and offer electives that will prepare students for the challenges of big data and computational biomedical research. The program will continue its mode of training that begins with a set of research rotations in laboratories of faculty members, and continues through doctoral research work under the supervision of a PhD advisor and co-advisor who provide complementary interdisciplinary expertise. The Program will also continue a recently established weekly Colloquium, the student Journal Club, and annual retreat. In the course of their training, program students have contributed important discoveries and impactful advances in health sciences research. Alumni of the program are placed in leading positions in Academia and industry. Given the extraordinary number and quality of applicants, the capacity and eagerness of the Program faculty to train the Program's students, and the institutional support for the Program, this application seeks to increase the number of trainee slots to 10. Following Training Grant support of Graduate students during their course work education and initial research training, all graduate students will be supported by their thesis advisors for the duration of thei PhD studies.

Public health relevance
PUBLIC HEALTH RELEVANCE: The purpose of this doctoral training program is to train students in the interdisciplinary area of Bioinformatics area of Bioinformatics and Systems Biology. The NIH has recognized that there is a critical need for such interdisciplinary training that integrates the biomedical, computational and engineering sciences, in order to harness the opportunities of the post-genomic era, to furthering the health sciences research and improving health care outcomes.